Advanced 7 Tesla imaging of the knee for root cause of Osteoarthritis

ABSTRACT:
The recent FDA approval of 7T for clinical imaging of the knee, opens the possibility that this ultrahigh field
MRI platform will become a more prominent tool in biomedical research and patient management.
Musculoskeletal (MSK) research and diagnostic imaging have been traditionally performed at magnetic
fields of 1.5 and 3T. While there is increasing availability of ultrahigh field (UHF) 7T instruments and FDA
approval of 7T clinical use in the head and knee, only a fraction of the system’s true capability is being
exploited. First, approval has only been given for operation in a single transmit mode configuration. As
such, clinicians cannot take advantage of the available parallel transmit (pTx) functionality to integrate
state-of-the-art solutions for tackling B1+ homogeneity and local SAR management. Even if available, the
RF coils and optimization routines to use the pTx functionality do not exist. Second, traditional diagnostic
imaging methods for evaluating the knee do not fully exploit the array of morphologic, compositional, and
functional data available when performing MRI at UHF. Both the traditional and novel imaging approaches
alike benefit from the increased signal-to-noise ratio at 7T. The increased sensitivity can be exploited to
provide higher resolution images that are known to have a real and significant impact on diagnostic
accuracy in the knee. Furthermore, certain methods are simply too compromised at lower field strengths
to be obtained as part of routine imaging at 3T and below including techniques like quantitative sodium
imaging and perfusion as measured through arterial spin labeling. In this proposal we focus on the
engineering, methodological and protocol developments to realize the full potential of 7T knee imaging
and provide a critical translational study focusing on the utility of the methods to impact clinical care. This
work will be accomplished by completing four specific aims. Aim 1 will focus on the development,
integration, and optimization of a pTx RF coil coil using ultrahigh dielectric constant (uHDC) material and
RF management strategies to provide high-resolution morphological knee imaging methods including zero
echo time imaging. Aim 2 will implement and optimizequantitative compositional and functional methods for
evaluating the knee joint at 7T including T1rho andarterial spin labeling (ASL) perfusion methods. Aim 3
will involve the development and optimization of a sodium (23Na) knee coil using uHDC material and
strategies for accurate quantification of 23Na concentration in the articular cartilage of the knee. Finally,
the translational Aim 4, will involve a pilot study to explore the ability of the developed technologies and
methods to impact patientcare. The technical developments in this proposal will advance knee imaging at
7T and likely accelerate its clinical adoption. The results of the pilot study are expected to have an immediate
and important impact,by forming the basis of future longitudinal prospective studies evaluating the effects
of medical treatmentson clinical outcome.

Public health relevance
PROJECT NARRATIVE: Osteoarthritis is the nation's most common cause of disability. Meniscal root tears are increasingly recognized as the root cause of OA and considered a previously unrecognized ‘silent epidemic’. Unfortunately, current clinical MRI, even at 3T fails to accurately inform treatment decisions. Utilizing higher resolution imaging and quantitative tissue characterization at 7T will improve pre-operative assessment and thus postsurgical outcomes. The aim of the proposed work is to develop the technology needed to unleash 7T UHF (ultra-high magnetic fields) to its full clinical potential.